Mechanisms of Chromosome Scale Signal Propagation

Project summary
The overall goal of this project is to determine how cells communicate chromosome break formation and
repair across large chromosomal distances. DNA double-strand breaks (DSBs) are dangerous insults to
genome integrity because of their potential to cause chromosome rearrangements and chromosome instability,
both of which are strongly associated with cancer progression as well as birth defects. Remarkably, meiotic
cells are able to efficiently orchestrate the formation and repair of hundreds of concurrent DSBs across their
genome during meiotic recombination, a process that is essential for proper gamete formation and fertility.
A key feature of meiotic DSB formation and repair is its coordination at the chromosomal level. In the
previous funding period we provided evidence that the synaptonemal complex, a conserved protein lattice that
forms between aligned homologous chromosomes in late meiotic prophase, communicates repair decisions
along meiotic chromosomes in S. cerevisiae. We showed that this communication resulted in reduced DSB
formation as well as simplified repair, and we identified several factors involved in this process. We now
discovered the existence of privileged genomic regions near the ends of all chromosomes that appear resistant
to regulation by the synaptonemal complex. These end-adjacent regions (EARs) cover large genomic
distances (~100kb, which is nearly half the length of the shortest chromosome) and continue to form and repair
DSBs well after DSB formation has stopped in the rest of the genome. Similar regions of elevated meiotic
recombination are also observed in birds, chimps, and humans.
The goal of this project is to define the chromosomal signal that generates these regions and to test if
EARs help inheritance of short chromosomes. Our preliminary analyses suggest several roles of the nuclear
envelope, both in the establishment of the EARs and in the suppression of DSBs in the rest of the genome.
The dynamics of chromosomal signaling and its interaction with the nuclear envelope will be analyzed by
genome-wide binding studies and super-resolution microscopy, taking advantage of a conditional nuclear
depletion approach that we recently introduced into meiotic cells that allows stage-specific knock-downs of
pleiotropic nuclear factors. In addition, signal integration will be analyzed using genetic epistasis analyses,
cytology, and physical analysis of DSB formation. As EARs cover a proportionally much larger fraction of short
chromosomes, the proposal will also use tetrad sequencing to test if these regions drive the widely observed
increase in recombination rates on short chromosomes. Fluorescent marker segregation will be used to
determine if EARs differentially improve the meiotic segregation fidelity of short chromosomes. Together, these
analyses will provide key insights into the mechanisms of chromosomal signal propagation, and open new
avenues for understanding the origins of birth defects such as Down syndrome (trisomy 21) and Edwards
syndrome (trisomy 18), which are caused by meiotic missegregation of short chromosomes.

Public health relevance
Project narrative Errors in packaging short chromosomes into sperm or egg cells are principally responsible for the high incidence of chromosomal birth defects such as Down syndrome (trisomy 21) and Edwards syndrome (trisomy 18). This project aims to determine the molecular mechanisms that specifically support the inheritance of short chromosomes in the model organism Saccharomyces cerevisiae, which, like humans, has a wide range of chromosome sizes. The results from this work will provide a general framework for the study of chromosomal birth defects in humans.